Neuroimaging Training Program

? DESCRIPTION (provided by applicant): Productivity in basic and clinical neuroscience research is accelerating due to technological advances in the area of biomedical imaging. These new technologies have the potential to advance knowledge about the underlying etiology of brain-based disorders, mechanisms of treatment, and predictors of response. This competing renewal grant proposal describes a Neuroimaging Training Program (NTP) established in 2003 within the framework of the longstanding and highly successful doctoral degree program offered by the Harvard-MIT Program in Health Sciences and Technology (HST). HST is an ideal home for the NTP. The sponsoring institutions, MIT and Harvard, and the affiliated teaching hospitals, have been and continue to be at the forefront of the development and application of biomedical imaging technologies. The faculty has consistently mentored leaders in the fields of biomedical imaging and clinical neuroscience. The integrated, interdisciplinary educational program trains students to meet the scientific, engineering, and clinical challenges posed by this area of investigation. Importantly, the curriculum creates a cohesive environment in which educators from both neuroscience and technology-based domains work and teach together effectively. The environment, mentorship, and formal didactic training attract exceptional individuals to the pursuit of clinical neuroimaging research. In the past two funding cycles, the NTP developed a comprehensive core curriculum and became established as an exceptional program for those wishing to pursue advanced training in neuroimaging. This renewal application builds on the initial success of the program and extends the program's positive impact. Specifically, the program plans to add faculty and training experiences in two new areas. First, the program will establish a new focus area in neuroimaging informatics. Second, using faculty members' extensive connections to industry, the program will expand the educational experiences so that trainees will have exposure to the broad range of areas that intersect with academic research-including, though by no means limited to, business development, intellectual property law, and financing (e.g., venture capitalism). This will provide them with in-depth understandings of how these areas operate, which are increasingly necessary to careers in neuroimaging, and help them develop networks that will prove integral to their careers.

Public health relevance
PUBLIC HEALTH RELEVANCE: Investment in training of biomedical engineers to become experts in the development of new non-invasive imaging tools and their use in patients with brain diseases such as schizophrenia and Alzheimer's Disease will greatly advance the ability to provide good medical care. The trainees from this program make significant contributions to medical technologies that enable accurate diagnosis of illnesses and determination of responses to treatments.